South African Research Ethics Training Initiative (SARETI) Leadership Program

PROJECT SUMMARY / ABSTRACT
ADMINISTRATIVE SUPPLEMENT TO SUPPORT FELLOWSHIPS AWARDED BY THE GLOBAL FORUM ON
BIOETHICS IN RESEARCH (GFBR)
The Global Forum on Bioethics in Research (GFBR) exists to provide a global platform for the exchange
and sharing of experience and expertise on research ethics among researchers, research policy makers
and ethicists, among others. Its core aims are to give voice to lo-w and middle-income country (LMIC)
perspectives in debates about global health research ethics and to promote collaboration.
The essential values of the GFBR include:
• the promotion of ethically conducted research;
• respect for the differences between many stakeholders in research – both geographical,
cultural, and scientific;
• the importance of bringing these together for mutual learning;
• the urgency of capacity building in health research ethics review in many LMICs;
• the need for partnership between north and south in capacity building in ethics and ethical
review in the south.
The GFBR Fellowships
The GFBR fellowships provide a unique opportunity for the Forum participants to work in partnership to
explore issues that have arisen during a GFBR meeting. There are three types of fellowship:
(1) TRAVEL: The GFBR travel fellowships are intended to support visits to a country other than the
country where the applicant is based. They are designed to give the applicant the time needed
to develop a topic and learn from being in a different research environment. The length of the
visit is usually between 2 weeks and 3 months. One of the key aims of the GFBR is to promote
new global South/South or North/South collaborations. The scheme is not designed to support
travel from one high income country to another;
(2) PROJECT: The GFBR project fellowships are intended to support specific projects, the outputs of
which may be conference presentations, academic papers etc. Please note that one of the key
aims of the GFBR is to promote new global South/South or North/South collaborations. It is
expected that any academic outputs are not sole-authored pieces or collaborations solely with
others from your current institution; and
(3) MEETING: The GFBR meeting fellowships are intended to support the costs of holding an event
that builds on the annual GFBR meeting discussion and furthers the GFBR’s aim to promote new
global South/South or North/South collaborations.
SARETI will administer the GFBR fellowship scheme which may include grants to travel, conduct
projects and/or hold meetings.

Public health relevance
PROJECT NARRATIVE ADMINISTRATIVE SUPPLEMENT TO SUPPORT FELLOWSHIPS OF THE GLOBAL FORUM ON BIOETHICS IN RESEARCH (GFBR) On behalf of the Global Forum for Bioethics in Research (GFBR), we wish to request an administrative supplement in the amount of US $50,000. The GFBR is currently managed by a Steering Committee (SC) consisting of (i) Katherine Littler, World Health Organization, Switzerland; (ii) Michael Parker, Oxford University, UK; (iii) Anna Chiumento, Liverpool University, UK; (iv) Teck Chuan Voo, National University of Singapore, Singapore; (v) Phaik Yeong Cheah, Mahidol Oxford Tropical Medicine Research Unit, Thailand; (vi) Sharon Kaur, University of Malaya, Malaysia; (vii) Anant Bhan, Yenepoya University, India; (viii) Jantina De Vries, University of Cape Town, South Africa; (ix) Caesar Atuire, University of Ghana, Ghana; (x) Ross Upshur, University of Toronto, Canada; (xi) Carla Saenz, Pan American Health Organisation, USA; (xii) Paul Ndebele, George Washington University, USA; and (xiii) Ana Palmero, National Ministry of Health, Argentina. Funder member representatives: Rachel Knowles, UK Medical Research Council, UK; Barbara Sina, Fogarty International Center, National Institutes of Health, USA and Dan O’Connor, Wellcome, UK are also members of the SC. These funds will be administered and disbursed by the NIH/Fogarty-funded South African Research Ethics Training Initiative (SARETI) on behalf of the GFBR. This project offers support for Masters-degree training in research ethics. SARETI has graduated 44 students to date and currently has about 6 students enrolled. Both SARETI and the GFBR seek to promote advanced research ethics capacity in developing countries through their respective programmes. More details of the SARETI program and the GFBR can be found in the by clicking on the following URLs: 1. SARETI – http://sareti.ukzn.ac.za ; 2. GFBR – http://www.gfbr.global/about-the-gfbr/ . In 2014, 2015, 2016, 2017, 2018 and 2019 we similarly administered some supplementary funds from NIH/Fogarty to support attendees at the 2014 GFBR which was held in Mexico City; the 2015 meeting held in Annecy, France; the 2016 meeting held in Buenos Aires, Argentina; the 2017 meeting held in Bangkok, Thailand; the 2018 meeting held in Cape Town, South Africa; and the 2019 meeting held in Singapore. This year, the requested supplementary funds will be used exclusively for fellowships as decided by the SC of the GFBR. The budget items that may be requested include, but are not limited to, the following: 1. Travel 2. Accommodation 3. Venue hire 1 4. Subsistence (but not if someone is conducting a project at their own institution) – this is more for travel fellowships or people attending a meeting and has also been offered to people engaged in a qualitative aspect of a project grant 5. Stipend 6. REC/IRB approval 7. Publication of a paper (though we try and steer people to WOR) 8. University/Institution administration fee 9. Materials and consumables (papers, pens, printing, software) 10. Translation services 11. Internet data 12. Laptop 13. Conference fee (e.g. attending a conference when on a travel fellowship. A fellowship fee just to attend a conference is not permitted). In addition to the above, the supplementary funds will also cover the following: 1. Modest support (to be calculated using UKZN hourly rates for support staff) for our project administrator to administer the funds and keep financial records in accordance with NIH and UKZN financial policies. 2